The roles of the COXs in normal physiology and in pathological conditions

The major goals of these studies are to elucidate the individual roles of COX-1 and COX-2 in normal physiology and in various pathological states. Specifically, effort within the laboratory has focused on using COX-1 and COX-2 deficient mouse ES cells and COX specific inhibitors to study the roles of COX-1 and COX-2 in endothelial cell development. Endothelial cell ifferentiation was measured immunohistochemically by the appearance of CD-31 staining cord like structures of cells and the appearance of VEGF receptors and COX-2 on Western analysis. Our studies indicated that neither the deficiency of COX-1 or COX-2 inhibited mouse ES cell differentiation into endothelial-like cells in vitro. However, studies with COX-2 selective inhibitors have indicated that the COX-2 inhibitors blocked endothelial-like cell development even in COX-2-/- ES cells, suggesting that a COX-2 independent mechanism was responsible.[unreadable] In addition, collaborative srudies demonstrated that COX-2 deficiency increased inflammatory responses in the mouse brain and but attenuates inflammatory responses in the mouse heart and abdominal vasculature.